Disrupted Ciliary Signaling in the Brain Pathology of Tuberous Sclerosis Complex

Tuberous Sclerosis Complex (TSC) is a multisystem genetic disorder affecting several organs. Individuals with
TSC suffer from refractory epilepsy, intellectual disabilities and autism spectrum disorder, and the neurological
manifestations are often the most disabling for these patients. Central nervous system (CNS) manifestations
include disorganized brain connectivity, increased astrogliosis, and presence of immature dysmorphic neurons.
Despite the fact that increased mTORC1 activity has been clearly implicated in the brain manifestations of TSC,
a critical unmet medical need remains to identify the downstream molecular pathways implicated in the abnormal
brain development. Ciliopathies are genetic disorders caused by mutations in genes affecting primary cilia which
are sensory cellular antenna with a role in brain homeostasis and development, thought to act as a key regulatory
node for sonic hedgehog signaling. Ciliopathies encompass a range of genetic disorders that share ciliary
dysfunction and can affect several organs, including the brain. This proposal builds on robust in vitro and in vivo
data indicating that certain brain abnormalities of TSC recapitulate the manifestations of ciliopathies with
alteration in the Shh signaling pathway. In particular, we found reduced ciliation in Tsc2-knockdown hippocampal
neurons, in neuronal-specific Tsc1 and Tsc2 conditional knockout mouse models and in the giant cells of the
cortical tubers of TSC patients. Notably, defective ciliogenesis was associated with an altered Shh signaling
pathway and presence of immature neurons. To gain insights into the molecular mechanism implicated in
defective ciliation, we performed a phenotypic screen in the Tsc2-deficient neurons and identified the heat shock
protein hsp90 as a drug target that reverses altered ciliation independently from mTORC1 hyperactivation. Using
a high throughput cell-based assay, we uncovered the existence of a therapeutic window for cilia restoration
through hsp90 inhibition, without affecting TORC1 activation. These findings enable us to build our central
hypothesis that hsp90 is the mTORC1 downstream target responsible for the ciliopathy-like phenotype seen in
TSC. Here, we propose to determine the mechanistic basis by which hsp90 inhibition restores cilia in Tsc2
deficient neurons using multiple pharmacological and genetic techniques and by identifying the hsp90
interactome in the TSC1/2 mutant neurons. Presence of immature neuronal properties, astrogliosis, and aberrant
regulation of the Shh pathway are some of the neuronal TSC manifestations that will be investigated to establish
the functional relevance of restoring cilia. Finally, we will first examine cilia in cortical neurons generated from
TSC patient-derived induced pluripotent stem cells (iPSCs) and their isogenic controls. We will perform
preclinical pharmacokinetics/pharmacodynamics (PK/PD) assessment of brain penetration and exposure of
hsp90 inhibitors in mice. Taken together, the outcome of these experiments will help elucidate the downstream
pathways affected by hsp90 in TSC, provide fundamental insights into cilia biology and potentially shed light for
other ciliopathies caused by dysfunctional heat shock response.

Public health relevance
Tuberous Sclerosis complex (TSC) patients suffer from autism, intellectual disability and epilepsy, and relatively little is known about the cellular mechanisms that result in these phenotypes. However, it is clear that primary cilia of neurons play critical roles in the formation and function of the nervous system. Therefore, defining the TSC1/2 related functions of primary cilia in neurons will be essential to understanding the pathogenesis of TSC in the brain and provide potential novel therapeutic interventions for the neurological manifestations of TSC. !